PPE Request

Project Abstract
On-going US government sponsored COVID-19 vaccine trials require screening, enrolling, and following over
150,000 volunteer study participants over 24-36 months. The trial participants are selected based on their risk
of COVID-19 infection, with trial participants coming from settings with high rates of community transmission,
groups with higher risk of progression to symptomatic disease, or both. Study staff working on COVID-19
vaccine trials interact with trial participants during scheduled trial assessments and unscheduled sick visits,
which includes high risk procedures such as nasal swabbing and performing physical examinations in often
poorly ventilated environments. As a result, a regular supply of personal protective equipment (PPE), including
surgical masks, face shields or goggles, gowns, and disposable gloves, is critical for their own protection and
for prevention of transmission within the clinic. This project will provide on-going PPE support to COVID-19
Prevention Network (CoVPN) trials across three continents, completing work anticipated through 2023.
1

Public health relevance
Project Narrative Surveillance, testing and monitoring of high-risk participants in COVID-19 vaccine efficacy, bridging and natural history studies remains inherently risky for participants and clinical staff. To safely conduct CoVPN trials, study teams need a steady and reliable source of PPE for both personal protection and to prevent secondary transmission within the clinics. Recognizing ongoing resource constraints and success of the current PPE program, this project will support the procurement and distribution of PPE to CoVPN trial sites through completion of ongoing studies through 2023. 1